Mechanisms of Behavior Change (MOBC) Initiative

The MOBC Initiative aims to understand the science of changing behavior. Human behavior is a complex dynamical system, with interacting parts at multiple scales. The MOBC attempts to support research to understand the system and ultimately contribute to better treatment options. This contract supports consortium management, Sharepoint Web service, etc.